ATHEROSCLEROSIS AND NONINVASIVE DETERMINATION OF ENDOTHELIAL ACTIVITY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Establish levels of endothelial activity in healthy young <50 years, healthy older >50 years subjects and patients with diagnosed coronary artery disease or peripheral arterial disease or patients diagnosed with diabetes mellitus, hypercholesterolemia or hypertensive patients. Goal is to identify the levels of endothelial activity related to the described pathologic states.